Consortium for Longitudinal behavioral and Social Science data Integration and Coordination (CLASSIC)

PROJECT SUMMARY/ABSTRACT
NIA has a rich portfolio of “deeply phenotyped” small- to mid-sized longitudinal studies which are an
underutilized resource of psychosocial, behavioral, and biomarker data. The long-term goal is to leverage
these single studies through collaboration and coordination in order to address replication, extend findings to
new contexts, and identify important factors that moderate healthspan and lifespan. The overall objectives of
this application are to address critical human and technological barriers to collaboration and coordination in
these deeply phenotyped studies. The central hypothesis is that these barriers relate to meta-data sharing
(inputs) and multi-study analysis (outputs). The rationale for this project is that addressing “input” barriers such
as PI reluctance and study team burden of meta-data sharing and “output” barriers such as difficulty accessing
data and lack of training in multi-study analysis will lower the burden for successful coordination across
studies, address broader replication questions, and empower smaller studies to fuel discoveries beyond their
initially funded aims. These objectives will be pursued by four specific aims: development of both technological
infrastructure (i.e., central distribution hub with publicly available meta-data catalog and
collaboration/coordination resources [Aim 1]) and human infrastructure (i.e., incentivizing study PIs and
engaging early career researchers [Aim 2], methodological support through workshops [Aim 3.1] and
consulting [Aim 3.2], and financial support [Aim 4] for multi-study analysis). The proposed research is
innovative, in the applicants’ opinion, because it develops tools and provides resources that reduce barriers for
both PIs (e.g., dashboard for tracking and attribution, incentivizing meta-data sharing) and early career
analysts (e.g., cross-study search and comparison tools, streamlined data requests). The proposed project is
significant because the resulting collaborations and multi-study analyses will systematically test whether
findings hold when tested in a diversity of sample characteristics, conditions, and across time. Ultimately, this
will provide more rigorous tests of aging theories and their boundary conditions, which will improve
understanding of aging and health.

Public health relevance
PROJECT NARRATIVE The proposed CLASSIC Network and OpenDRaWeR meta-data catalog will address infrastructure barriers to collaborative and coordinated research in the NIA’s rich portfolio of small- to mid-sized deeply phenotyped longitudinal studies. It is relevant to public health because it will increase generalizability of findings related to behavioral, biological, and psychological aging by facilitating analysis across diverse samples and designs. Reproducible findings which are held across diverse samples and time periods are essential for understanding and addressing changes in health with age, thus, the proposal is relevant to NIH’s mission to reduce illness and disability.